NBER Roybal Center for Behavior Change in Health

SUMMARY/ABSTRACT
NBER Roybal Center for Behavior Change in Health – Overall
Health outcomes are affected by myriad mechanisms, including behaviors. An important question is how such
behaviors might be influenced in ways that improve health outcomes on a broad population-wide scale. The
NBER Roybal Center explores this question by conducting carefully-designed experimental interventions with
analytic and theoretical foundations in the behavioral sciences. The interventions are selected to be cost-
effective and scalable. Among the categories of health-related behavior we plan to study are interventions to
improve nutrition; interventions to increase exercise; interventions to overcome addiction, including tobacco,
alcohol, and opioids; interventions to promote preventive care, including vaccinations and incremental utilization
of workplace wellness programs; interventions to improve medical adherence, including the filling of
pharmaceutical prescriptions; and interventions to improve the decisions of health care providers, including
applications of machine learning. The research plan is strengthened by a partnership with Geisinger Clinic, a
non-profit health care network and insurer with a rich history of innovative delivery reforms and experimental
research to improve population health in an active, well-integrated, health care delivery and community health
setting. The NBER-Geisinger partnership provides a core infrastructure for implementing experimental
interventions on-site with an engaged and committed health care delivery partner. The Center also engages a
collaborative network of leading behavioral scientists from multiple disciplines who conduct the experimental
interventions, share research activities and findings, collaborate on joint projects, and brainstorm new
intervention opportunities, building from findings in basic science. This application renews the NBER Roybal
Center for the next five years.

Public health relevance
PROJECT NARRATIVE – PUBLIC HEALTH RELEVANCE Health is a foundational source of wellbeing for people of all ages. As resilient as human physiology may be, and as random and unexpected as health events may be to any particular person at any particular time, health is also affected by the lifestyle decisions that we make, our behavioral interactions with the medical care system, and how we respond to adverse health events when they occur. The NBER Roybal Center for Behavior Change in Health will take research from basic science and translate it into applications that address real-world problems in ways that directly, broadly, and cost-effectively improve population health.